Malaria Parasite Ligands And Host Cell Receptors

Accomplishments during the year: 1. The immune response to AMA1 combined with RON2 has been studied. This work continues to expand our understanding of parasite invasion of red cells by identifying the receptors and ligands and determining the potential of these targets for vaccine development. 2. The knockout of a PfSET gene (named PfSETVS) leads to expression of all var genes, indicating that PfSETvs silences var genes. 3. We have identified some small molecules that block junction formation and invasion. 4. We are studying the pathway of phosphorylation by P. falciparum kinases. 5. We continue the study of the mechanism of red cell invasion by P. falciparum and P. vivax.